High-Speed, wide field fluorescent imaging of cortex in freely moving animals

The study of neuronal activity in awake, freely moving animals is the most representative view of [unreadable]normal[unreadable] neuronal function. Anesthetics and restraint have profound effects on neuronal physiology and the correlate animal behavior. The study of real time neuronal event processing requires recording methods with high temporal bandwidth (>500 Hz) and the ability to detect physiologically relevant events (i.e. voltage changes). Currently only microelectrode recording of single neuronal units, multiunit activity and field potentials have sufficient temporal resolution and portability to allow recording of neuronal activity in freely moving animals. The proposed project will produce three miniature microscope/imaging systems which can be head mounted and will allow the optical recording of changes in membrane voltage neurons in freely moving rats. During the first year of the funded two-year ARRA project, a prototype device and image sensor was developed that can collect wide field image sequences of fluorescent voltage dye signals. The current application will i) complete the fabrication and operationalize a head mountable fluorescence microscope. This includes design and fabrication of a novel imaging sensor, custom optics, a stabilized illumination source and a form fit microscope body with head mount. This project will also develop a modified version of the microscope for use with fluorescence resonance energy transfer probes, allowing simultaneous imaging of dual wavelength emissions. The studies proposed herein will also build and test a novel fluorescence microscope design that will reduce the height of the traditional microscope by eliminating the 45[unreadable] dichroic mirror. ii) The proposed studies will also modify our current camera control and recording system to be fully contained in a back pack on the rat. This back pack will contain a field programmable gate array, heat exchanger/coolant pump and a battery to run the microscope autonomously. iii) Finally the instrument will be tested in imaging studies of the rat somatosensory cortex (barrel cortex). Transcortical responses to object discrimination will be studied in freely moving rats. These studies will systematically engineer each component to maximize excitation light delivery, fluorescent light collection and optical resolution while minimizing weight, volume, energy usage and heat generation. The device will be capable of recording rapid (1 kHz) fluorescent image sequences of a 2-4 mm2 area of cortex and detect small changes in deltaF/F (0.1%). The device will be small (<1.8 cm2 head mounted) and light weight enough (15g) to be mounted on the head of a freely moving rat. The device is intended as a precursor to devices that can translate neuronal activity into actions in real time, optical brain machine prosthetic.

Public health relevance
This project will develop a device to study brain function in awake, behaving mammals. The device represents the first step in the development of a neuroprosthetic device to capture information from neuronal tissue containing intended functional output. Such a device can ultimately be used to allow direct brain control of robotics, computers and instrumentation to allow paralyzed patients a way to exert conscience control of their environment.